Regulation and functional contribution of hypothalamic modified adult hippocampal neurogenesis

Project Summary
The hippocampus has considerable importance for memory and emotion, and it is a major site of
pathophysiology associated with various neurological and psychiatric disorders. One striking feature of this brain
region is its unique capacity for adult neurogenesis, a process by which new neurons are continuously generated
from radial neural stem cells (rNSCs) throughout life in the dentate gyrus (DG). These adult-born neurons (ABNs)
undergo a critical period of heightened synaptic plasticity, during which they make unique contribution to
hippocampus-dependent behavior. Adult hippocampal neurogenesis (AHN) is dynamically regulated by neural
circuit activity. However, a long-standing question remains on whether manipulating neural circuits can induce
sufficient neurogenic effects for behavioral modulation. Recently, we identified a key subcortical region in the
hypothalamus, supramammillary nucleus (SuM), which upon activation effectively promote AHN. Specifically,
patterned stimulation of SuM neurons promotes self-renewal and neurogenic proliferation of rNSCs and
maturation of ABNs, which collectively contributes to increased production of ABNs with improved properties.
Importantly, chemogenetic manipulation of the activity of these SuM-enhanced ABNs bidirectionally modulates
memory performance and innate anxiety. These results highlight activity-dependent contribution of SuM-
enhanced ABNs in hippocampal function. Interestingly, SuM neurons are highly responsive to environmental
novelty (EN) and are required for EN-induced enhancement of neurogenesis. Building upon these findings, we
propose the following aims to decipher mechanisms underlying SuM-mediated modulation of AHN and activity-
dependent contribution of SuM-enhanced ABNs to brain-wide network dynamics. Aim 1 will determine the
contribution of SuM glutamate or GABA transmission in mediating SuM-activity or environmental-novelty induced
enhancement of hippocampal neurogenesis. Aim 2 will determine the functional properties of SuM-enhanced
ABNs and molecular regulators underlying SuM-mediated enhancement of neurogenesis. Aim 3 will determine
activity-dependent contribution of SuM-enhanced ABNs to local hippocampal circuit and brain-wide network
dynamics.

Public health relevance
Project Narrative Adult hippocampal neurogenesis plays a critical role in regulating memory and emotion, and this process is dynamically regulated by neural circuit activity. We recently identified a key subcortical region, supramammillary nucleus (SuM) in the hypothalamus, that robustly modulates hippocampal neurogenesis. Our proposal aims to decipher mechanisms underlying SuM-mediated modulation of AHN and activity-dependent contribution of SuM- enhanced ABNs to brain-wide network dynamics.